Component A: New York City Pregnancy Risk Assessment Monitoring System, a surveillance system of maternal experiences and behaviors around the time of pregnancy to inform local programs and policies

Component A: Core Surveillance
Project Summary/Abstract
The Bureau of Maternal, Infant, and Reproductive Health (BMIRH) of the New York City (NYC)
Department of Health and Mental Hygiene (DOHMH) proposes to continue the Pregnancy Risk
Assessment Monitoring System (PRAMS) in NYC. PRAMS is a surveillance system to identify and
monitor maternal experiences and behaviors around the time of pregnancy. The overall goal of
BMIRH is to achieve equitable and improved maternal, infant, and reproductive health outcomes in
NYC. Three overarching objectives are to: 1) reduce racial and ethnic inequities in infant mortality; 2)
reduce racial and ethnic inequities in preventable severe maternal morbidity and maternal mortality;
and 3) reduce racial and ethnic inequities in access to contraceptive information and services among
youth ages 13-19. Data gathered from PRAMS will be linked to items from the birth certificate,
offering a unique source of information on maternal, infant, and reproductive health in NYC.
Each month approximately 180 women who gave birth in the previous two to four months will be
randomly selected from NYC birth certificate records to participate in PRAMS. Women who give
birth to low birthweight infants (<2,500 grams) will be oversampled. Women will be contacted by
mail, with telephone follow-up for non-respondents. To ensure adequate participation, women will be
sent $20 cash with the first mailing of the survey. Additionally, the PRAMS survey will be available in
English, Spanish, and Chinese. The data collection cycle for each monthly sample will lasts up to 95
days. The DOHMH will contract with the Bloustein Center for Survey Research (BCSR) at Rutgers,
the State University of New Jersey, for data collection and management activities. BCSR has
experience working with several PRAMS jurisdictions and consistently produces high-quality data
while adhering to the Centers for Disease Control and Prevention (CDC) protocol.
PRAMS data will be weighted by CDC to represent NYC resident women giving birth in NYC. The
specific aims of the project are to use PRAMS data to inform NYC's priorities related to improving
maternal and infant health, and its choice of programs, policies, and activities toward that end.
PRAMS data will also serve as a NYC-specific data source for monitoring key Healthy People 2030
and Health Resources and Services Administration (HRSA) Maternal and Child Heath Bureau
indicators. The DOHMH will partner with academics, community groups, providers, government
agencies, and professional organizations to ensure PRAMS data are used to support programs and
policies to improve maternal and infant health.

Public health relevance
Component A: Core Surveillance Project Narrative The New York City Pregnancy Risk Assessment Monitoring System will provide population-based surveillance data of high scientific quality on maternal attitudes, experiences, and behaviors before and during pregnancy as well as early infancy. These data are not available from any other source and thus are important for developing and evaluating programs and policies aimed at improving maternal and infant health in New York City. The data will also serve to monitor progress towards select national Healthy People 2030 indicators.